Training Program in Immunology and Inflammation

ABSTRACT
The Immunology and Inflammation training program at NYU Grossman School of Medicine (NYUGSoM)
provides excellent pre-doctoral and post-doctoral training at the interface between immunology and
human disease. The program trains students and postdoctoral fellows in basic immunology as well as its
applications in host-pathogen interactions, autoimmune and inflammatory diseases, and anti-tumor
immunity. Innovative courses provide trainees with a foundation in the field and training in critical
evaluation of data, and the students build on this foundation in the weekly immunology seminar series
and journal club. Trainees develop their writing and presentation skills through participation in work-in-
progress presentations, journal clubs, and an annual retreat. A critical element of training is research
experience, and the training program currently has 30 faculty who are highly productive scientists with
extensive mentoring experience. In addition, NYUGSoM is undertaking a major expansion of its
immunology research base. The first two cycles of the program supported many highly successful
trainees, and we propose to build on this success with a training program with 4 pre-doctoral and 2 post-
doctoral positions. The long-term goal of the program is to train a new cadre of rigorous and creative
researchers in the broad and interdisciplinary area of immunology and its relation to inflammatory
processes. The successful trainees will be ideally positioned to contribute to the development of novel
therapies to treat inflammatory diseases.

Public health relevance
PROJECT NARRATIVE Inflammation is a basic immunological mechanism that helps to protect the host from injury and infection under normal physiological conditions. Pathological inflammation is a pervasive component in many human diseases including chronic infections, autoimmune diseases, vascular and neurological diseases, and cancer. Training a new generation of the brightest scientists in the study of immunology and inflammation will facilitate the understanding and ultimately treatment of multiple diseases of public health importance.